A behavioral economic intervention for low-income smokers - Resubmission - 1 - Revision - 1

PROJECT SUMMARY
People with low income face unique barriers to cessation, including high levels of financial distress, trauma, and
unmet social needs, resulting in the use of smoking as a coping mechanism. Behavioral economics further finds
that people experiencing financial hardship must attend to their immediate needs for survival at the expense of
delayed goals (such as the long-term health benefits of quitting smoking). Interventions that alleviate financial
hardship and other social needs may improve quit rates in this population. Our parent R37 grant is evaluating
the effectiveness, behavioral economic mechanisms, and cost-effectiveness of an intervention that integrates
financial coaching and referral to financial empowerment services and social services into smoking cessation
treatment. Recent trauma-informed theories of behavior suggest that intervention approaches that that shift the
focus away from individual determinants of tobacco use to the social and structural determinants tobacco use
may improve intervention engagement and effectiveness by creating a more holistic, non-judgmental and
resilience-oriented smoking cessation process. Additionally, participants with multiple marginalized social
identities may have unique experiences and smoking cessation processes while participating in interventions
that acknowledge one’s broader lived experience and social determinants of tobacco use. Lastly, co-occurring
health conditions, such as poor sleep hygiene, may interact with tobacco cessation interventions but these
interactions have been under-studied in the literature. The overall objective of this administrative supplement is
to use qualitative methods to identify multi-level factors not included in the original R37 proposal that may
enhance or limit the intervention’s impacts on treatment engagement, initial smoking cessation, and long-term
cessation maintenance. The qualitative results will be further used to inform the selection of new quantitative
measures to include in the parent R37 grant’s data collection and analytic approaches to provide insights into
why the intervention works, for whom, and in which contexts. The Specific Aims of the proposed supplement are
to: Aim 1) Qualitatively examine intervention-related and context-related factors that may enhance or limit the
intervention’s impacts on treatment engagement, initial smoking cessation, and smoking cessation maintenance,
with Sub-Aim 1.1) Explore how social factors and other health conditions may interact to influence participants’
intervention experiences, behavior change processes, and the intervention’s potential mechanisms of action.
Aim 2) Guided by the qualitative themes identified during Aim 1, select new multi-level quantitative measures to
include in the parent R37 grant’s data collection and analytic approaches to enhance the parent project’s
understanding of the intervention’s key mechanisms of action and contextual influences. The results are
expected to generate important insights about interventions that address sociocontextual determinants of
tobacco use in people with low income who smoke.

Public health relevance
Project Narrative The proposed administrative supplement will add qualitative methods to the current grant to identify individual and interpersonal mechanisms of action—and contextual moderators—of an intervention that targets poverty as a key social determinant of tobacco use among adults with low income. Study results will address significant gaps in knowledge about why the intervention may or may not work, for whom, and in which contexts.